Role of BAP1 in the biphasic life cycle of KSHV

PROJECT SUMMARY / ABSTRACT
Kaposi's sarcoma-associated herpesvirus (KSHV) is an oncogenic gammaherpesvirus with a biphasic life cycle
consisting of a latent and lytic phase. KSHV is the etiological agent of several diseases and cancers including
Kaposi's sarcoma and primary effusion lymphoma (PEL). Initial infection in oral epithelial cells supports the lytic
phase, allowing KSHV to replicate and produce infectious virions. Spread from the oral cavity to B cells in lymph
nodes results in latency establishment, characterized by repressed lytic genes imparted by
heterochromatinization of the viral genome not seen in oral epithelial cells. As a result, the virus is able to evade
immune detection and promote tumorigenesis primarily in immunocompromised hosts. We aim to identify host
factors that are involved in promoting the KSHV life cycle so as to identify potential targets for therapeutic
interventions. We have shown that the viral prolytic protein ORF45 interacts with lytic cycle-promoting host
transcription factors FOXK1/2. Interestingly, we also discovered the presence of a functional motif on ORF45
that is known to be present in various host proteins including BRCA1-associated protein 1 (BAP1) and promotes
their interaction with FOXK1/2. BAP1 acts as a tumor suppressor with its loss of function mutations implicated
in a wide range of cancers which interrupt its normal cellular functions such as its deubiquitinase activity that
antagonizes heterochromatin formation and its regulatory role in cell proliferation. Yet in virus-induced cancer
contexts and during lytic viral infection, BAP1 remains uncharacterized. Our preliminary data reveals a
contrasting, context-specific role of BAP1 during KSHV infection, with pro-lytic activity during lytic infection of
oral epithelial cells but pro-latent functions during latency in PEL cells. Our goal is to dissect the mechanisms
whereby BAP1 promotes KSHV lytic infection in oral epithelial cells, and maintains latency and regulates tumor
proliferation in PEL. The goal is to provide future therapeutic considerations to reduce virus transmission in the
oral cavity and prevent life-long persistent latency that leads to cancer burden.

Public health relevance
PROJECT NARRATIVE Kaposi's sarcoma-associated herpesvirus (KSHV) is an oncogenic gammaherpesvirus with a biphasic latent and lytic life cycle responsible for oncogenesis and viral spread, respectively. The work detailed in this proposal focuses on a host tumor suppressor protein that, we discovered, possesses a contrasting role during the latent versus lytic phase of KSHV. This study aims to reveal context-specific mechanisms that govern viral hijacking of a host tumor suppressor protein function to promote its life cycle and pathogenesis.